D4T VS DDI VS ZDV PLUS D4T VS ZDV PLUS DDI IN HIV INFECTED PATIENTS

Phase II, randomized study of virologic and immunologic effects of various nucleoside reverse trannscription inhibitors in patients with 300-600 CD4 cells.